Dysfunctional behavior with friends during middle childhood as a precursor to borderline personality pathology - Supplement

PROJECT SUMMARY/ABSTRACT
The purpose of this administrative supplement is to support Dr. Vanwoerden’s work on mentored career
development K01 in the face of her upcoming critical life event, the birth of her first child. This supplement will
support continuity of Dr. Vanwoerden’s research and overall productivity during a critical juncture in her career
by providing funds to support a research specialist (RS). Together with funds from the parent award, this RS will
be available on a full-time basis to help Dr. Vanwoerden with recruitment and scheduling of participants as well
as in-person data collection during and following her planned time off. This extra support is critical to allow data
collection to proceed on the timeline proposed in the parent K01 award, which involves hard-to-recruit sample of
child-friend pairs with their respective mothers. Having a full-time RS after Dr. Vanwoerden returns on leave will
be equally important to maintain progress in data collection while allowing Dr. Vanwoerden the time to process
and analyze data, write papers, and complete training aims outlined in the parent K01 award as she manages
with increased caregiving responsibilities. This supplement support is needed during a sensitive time in Dr.
Vanwoerden’s career and will meaningfully influence her retention in the field of research and provide support to
reach full research independence. There will be no changes to the aims, research design, and methods of the
current project.

Public health relevance
PROJECT NARRATIVE Borderline personality disorder (BPD) is a serious mental illness associated with comorbidity across internalizing and externalizing pathology as well as high personal and societal cost. This study will use a high-risk design to assess problematic interpersonal behavior exhibited by children with their friends to determine whether it reflects a precursor to BPD or other internalizing and externalizing problems. Results will provide critical information about hypothesized disease trajectory for BPD, which will inform targets for prevention and early intervention.